Molecular choreography and trafficking in the aging myocardium

Project Summary
Aging is an independent risk factor for cardiovascular disease and with an aging global population there is an
urgent need to increase health-span alongside the already increased lifespan, allowing people to live
independent and healthy lives well into their old age. Cardiac aging is inevitably accompanied by a progressive
deterioration in cardiac function, including loss of responsivity to β-adrenergic receptor signaling and impaired
myocardial relaxation resulting in diastolic dysfunction but the molecular mechanisms that drive these functional
deficits are not understood. Recent progress has identified prominent signs of endosomal pathway dysfunction
in ventricular myocytes from old hearts, including endosomal enlargement and impaired endocytosis and
recycling of sarcolemmal L-type Ca2+ channels, impairing their ability to respond to acute stress. The endosomal
pathway regulates and controls the expression of sarcolemmal proteins by orchestrating their endocytosis,
sorting, and subsequent recycling or degradation. Defects in this pathway are linked to aberrant protein
aggregation and neuronal pathology in a host of neurodegenerative diseases, but most famously Alzheimer's
disease. Abnormal protein aggregation is also a feature of cardiac aging. These aggregates are thought to
contribute to diastolic dysfunction by stiffening the ventricles. In this project we hypothesize that age-associated
deterioration of the endosomal pathway is a driver of the age-associated decline in cardiac function. This
hypothesis will be rigorously examined in three specific aims. The first will study the broad consequences of age-
associated endosomal traffic jams on cardiomyocyte sarcolemmal proteostasis, impaired stress responses and
diastolic dysfunction by examining membrane protein expression and recycling in young and old ventricular
myocytes. The second will examine the influence of altered phosphoinositide metabolism on endosomal
dysfunction in the aging heart by resolving PI species levels in various membrane compartments using specific
biosensors and lipid mass spectrometry. The final aim will investigate the impact of aging on endosomal
trafficking and localization of key proteins involved in the endosomal pathway, with the goal of restoring youthful
endosomal function using stabilizing chaperones and/or AAV9 packaged shRNA approaches. By addressing
these specific aims, we hope to shed light on the intricate interplay between aging, endosomal trafficking, protein
aggregation, and cardiac dysfunction. The findings from this comprehensive investigation may identify novel
targets for development of therapeutic strategies aimed at mitigating the adverse effects of aging on
cardiovascular health and to extend healthspan
in the elderly.

Public health relevance
Project Narrative This project investigates the role of endosomal pathway dysfunction and accompanying traffic jams in cardiac aging, examining the impact on the regulation of sarcolemmal protein expression, and links to βΑR hyporesponsivity, and diastolic dysfunction. We propose that endosomal traffic jams are upstream drivers of the age-associated decline in cardiac function. The preliminary discoveries provide a glimpse of this unexplored realm in the aging heart, revealing pathogenic overlap with Alzheimer's disease and promising ramifications for cardiac physiology. broad